Deciphering microbial contribution to androgen bioavailability in castration resistant prostate cancer patients

PROJECT SUMMARY
An emerging role of microbiome in cancer is the capacity of microorganisms to impact treatment, drug efficacy
and metabolism. For example, we recently showed that the gut microbiome plays an important role in castration
resistant prostate cancer (CRPC) through microbial-derived androgen synthesis (Pernigoni et al. Science.
2021;374(6564):216-224). In that study, we found that androgen deprivation in both mice and humans promotes
the expansion of specific gut bacteria capable of converting testosterone precursors into active testosterone,
through bacterial CYP17A1-like enzymes (Ruminococcus gnavus, Ruminococcus sp. and Bacteroides
acidifaciens), thus increasing its levels in patients and mice with CRPC and preventing complete suppression of
testosterone during androgen deprivation therapy. In addition to the biosynthetic route, testosterone
bioavailability could represent an additional means to regulate therapeutic responses. Androgens are
glucuronidated in the liver for elimination and a fraction of these glucuronidated androgens reaches the gut
through the bile and are targeted by bacterial β-glucuronidases (GUS) (Ruminococcus gnavus, Ruminococcus
sp., Bacteroides acidifaciens and Clostridium scindens) for “reactivation” and potentially reabsorption. In fact,
androgen concentration is higher in the intestine than in serum of human males. Another route by which gut
microbiota contribute to the bioavailability of androgens is through cortisol to 11β-Hydroxyandrostenedione
conversion by bacterial steroid-17,20-desmolases (Clostridium scindens desABCD operon). In turn, 11β-
Hydroxyandrostenedione is converted to 11-oxyandrogen, which contribute to the tumor androgen pool. It is
unclear how much each of these different routes contribute to the pool of circulating androgens. Our central
hypothesis is that gut microbiome contributes to the production and bioavailability of androgens through a
combination of biosynthetic and bioavailability routes. The objective of this project is to computationally identify
androgen-related bacterial enzymes (CYP17A1-like, GUS, desA and desB) in CRPC patients gut microbiome
and to isolate bacterial species harboring those enzymes for functional analysis. The rationale for the proposed
research is that the outcomes will provide targets for future development and evaluation of interventions in CRPC
patients that minimize or prevent the bioavailability of androgens. Our hypothesis will be tested through two
specific aims: Aim 1) Identify androgen-related bacterial enzymes in the gut microbiome of prostate cancer
patients. Aim 2) Functional characterization of bacterial species possessing androgen-related enzymes. At
completion, this project will identify bacterial enzymes involved in androgen biotransformation and biosynthesis
and obtain bacterial species harboring these enzymes. This knowledge will serve as a springboard for future
functional studies using preclinical models of CRPC and inhibitors targeting bacterial androgen biotransformation
and synthesis enzymes and/or species that harbor them to alleviate CRPC, thus providing an innovative
approach to slow or prevent prostate cancer progression.

Public health relevance
The proposed research focuses on prostate cancer, one of the most frequently diagnosed cancers in men in the United States, and will identify bacterial enzymes involved in androgen biotransformation and biosynthesis in addition to obtaining bacterial species harboring these enzymes. This knowledge will serve to develop novel agents acting as potential inhibitors for the bacteria themselves and/or their androgen related enzymes, which could have a major impact on prostate cancer progression due to androgen bioavailability from bacterial sources. The project supports the foundation of an innovative approach to slow or prevent prostate cancer progression.